Preventing Graft Thrombosis in the Elderly through Development of a Risk Prediction Tool

Bypass graft and/or stent thrombosis resulting in loss of blood flow to the lower extremity is a leading cause of
amputation in elderly patients (aged ≥60 years), with an incidence of up to 17%. These amputated elderly
patients suffer 1-year mortality as high as 50%; hence, preventing graft/stent thrombosis is critical. The most
common etiology driving graft/stent thrombosis is hypercoagulability (increased blood clotting propensity).
Current strategies to prevent graft/stent thrombosis rely on anti-platelet and anticoagulant medications, but
managing thromboprophylaxis in elderly patients is challenging as they have high opposing risks of both life-
threatening thrombosis and hemorrhage; therefore, targeted, timely anticoagulant-prescribing is especially
important. Hypercoagulability in these patients after surgery to revascularize extremities with impaired blood flow
can be transient, so the current standard practice of starting anticoagulation to combat temporary thrombotic
propensity increases the risk of hemorrhage during the months post-procedure. There is presently no way to
accurately predict which elderly patients are at risk of thrombosis at a point in time post-limb revascularization to
guide targeted, safe anticoagulation therapy. Hence, the goal of this proposal is to define objective, individualized
metrics to identify elderly patients at high risk of thrombosis and guide thromboprophylaxis strategies to improve
the care of elderly patients. Our preliminary data reveal that point-of-care coagulation tests can identify transient
elevations of coagulation status that are uniquely amplified among elderly patients who develop graft thrombosis.
Furthermore, whole-blood thromboelastography (TEG) and platelet mapping (PM) identified the onset of
hypercoagulability prior to a thrombotic event. These findings advance beyond prior research by showing that
longitudinally acquiring multiple automated measures (in a single blood sample per time point) of individuals'
coagulation parameters and incorporating them into risk-scoring tools can help predict which elderly patients are
at risk of graft thrombosis, and when they are at highest risk, to improve and long-term clinical care. When
combined with clinical variables, such a tool could enable early, targeted anticoagulant intervention that can
prevent clotting complications, thereby reducing the risks of amputation and death. Based on these novel
findings, we hypothesize that combining longitudinal coagulation assays (TEG/platelet mapping/thrombin
generation) with clinical variables in a risk-prediction model will enable identification of elderly patients who are
risk of graft thrombosis. The aims of this project are to: (1) Identify individual hypercoagulability patterns among
elderly patients at risk of extremity graft/stent thrombosis to delineate hyperactive components of the coagulation
cascade; and (2) Develop and validate a novel and personalized risk prediction tool for extremity graft/stent
thrombosis in elderly patients. The results will yield a novel, individualized risk-prediction tool that can identify
elderly patients at high risk for graft/stent extremity thrombosis and guide clinical decision-making to improve
safe and effective thromboprophylaxis strategies for this vulnerable population.

Public health relevance
Project Narrative Hypercoagulability is the most common etiological factor in bypass graft/stent thrombosis/clotting in elderly patients and may lead to limb amputation. The current “one size fits all” approach to anticoagulation to prevent graft/stent thrombosis increases the risk of bleeding and clotting events in the months post-procedure. The goal of this application is to define objective, individualized clotting factor metrics to identify elderly patients at increased risk of thrombosis and develop and validate a novel, personalized risk prediction tool that can be used to identify elderly patients at high risk for graft/stent clot and guide clinical decision making in pursuit of the safest and most effective anticoagulation strategies for this vulnerable population.